Building transgenic tools in Acomys cahirinus, an emerging model for mammalian regenerative biology and healthy aging

Project Summary
Many of the major biological discoveries of the 20th century were made using very few model species. They
were chosen for historical tractability, rather than biological attributes relevant to critical biological questions or
relevance to pressing global health issues. However, the advent of new sequencing and genome engineering
technologies makes establishment of new genetic models feasible. History has demonstrated that the success
of model organisms is self-perpetuating: as the community of researchers grows, new methodologies and
resources are developed and shared, and the body of specific knowledge and access to powerful tools to
manipulate, observe and experiment upon these model organisms further lowers the bar to entry so that the
cycle can repeat (18). Here we propose to develop transgenic infrastructure for Acomys cahinirus an emerging
model of adult mammalian non-fibrotic regenerative healing and healthy aging. We have propose a methodical
comprehensive and feasible plan to achieve transgenesis in Acomys. We first propose the generation of
interspecies Mus musculus Acomys leveraging Acomys ES cells which we have generated and CRISPR
tagged with a fluorescent marker. We will then work to generate whole animal transgenic Acomys animals
using a variety of ex vivo and in situ methodologies. Acomys transgenesis will unlock the genetics of the
extraordinary regenerative biology of Acomys certain to yield novel therapeutic approaches to human health
and disease.

Public health relevance
Project Narrative Traumatic injuries, fibrotic diseases, scarring, chronic inflammation, and aging impact multiple organ systems affect millions of people worldwide at great economic cost. We propose to develop transgenic technology in Acomys cahirinus (Spiny mice); the only mammal known to retain extensive regenerative, non-fibrotic wound healing as adults. This technology will enable us to unlock the mysteries of mammalian regenerative healing and define much needed new therapies for human regenerative medicine and aging.